Administrative /BioStatistical Core

This core will serve all projects by providing administrative support, organization of External and Internal Advisory Groups, overall leadership via the Program Director, Dr. Lipton, and also statistical support to help plan and analyze all experiments. For example, power analyses will be performed to help investigators decide on how large an in vivo experiment to plan, how many animals to use, and what endpoints are realistic in terms of obtaining statistically significant results.